Simultaneous Diagnosis of Dengue and Prognosis of Severe Dengue with a Single Point-of-Care Test

Dengue is the most common mosquito-borne viral disease and the cause of tremendous morbidity, mortality
and economic burden. Yearly, there are an estimated 390 million (M) Dengue virus (DENV) infections, 96M
symptomatic cases of Dengue Fever, and 0.5M cases of Severe Dengue. Untreated Severe Dengue has a
fatality rate of 20-40%, but the fatality rate drops to less than 1% with timely in-hospital care. Unfortunately,
Severe Dengue is now detected only by skillful observation of clinical warning signs, and progression to severe
disease can occur within hours, making effective care difficult. Therefore, there is an urgent need for
prognostic tests that can identify patients most likely to progress to Severe Dengue. There are four serotypes
of DENV and infection with any one serotype generates strong, potentially life-long immunity to reinfection by
that same serotype, due to development of neutralizing antibodies against serotype-specific epitopes.
However, most antibodies induced by first infections are cross-reactive and non-neutralizing, and paradoxically
can increase the risk of Severe Dengue in patients who suffer a later infection with a different serotype, due to
a phenomenon termed Antibody-Dependent Enhancement (ADE). Heterotypic secondary infection is the
major accepted risk factor for Severe Dengue but heterotypic secondary infections cannot now be identified
within the time available for decision making to impact clinical care and outcome.
We propose to create a simple, inexpensive, Point-of-Care (POC) test with visual plus/minus readout
that will not only diagnose DENV infections early, but also be prognostic for Severe Dengue by quickly
identifying patients who have secondary heterotypic infections.
Phase I will create key biomarker detection reagents and incorporate them into two sets of serotype-specific
Lateral Flow Assays (LFAs): 1) antigen LFAs to diagnose and serotype current infections (by detecting DENV-
NS1 made during active infections), and 2) antibody LFAs to diagnose and serotype past infections (by
detecting anti-DENV-antibodies made by patients in response to previous infections). Phase II will combine
the individual assays in a single dual reporter LFA and then generate analytical and clinical performance data
to support applications for CE Mark and FDA 510(k) clearance as a POC IVD.
Innovation: The proposal creatively combines a well-established clinical observation (heterotypic secondary
infection is the major risk factor for Severe Dengue), with two significant technical advances:1) rapid serotyping
of current infections, and 2) rapid serotyping of past infections. With this combination we will develop a first-in-
class POC test for DENV diagnosis and Severe Dengue prognosis that will change clinical practice.
Impact: A simple, inexpensive POC test that provides timely prognostic results even in resource-limited
settings would enable dramatic reductions in Dengue morbidity and mortality while reducing health care costs
by allowing clinicians to focus resources effectively and efficiently on patients who may need them most.

Public health relevance
There is an urgent need for prognostic tests that can identify Dengue patients most likely to progress to Severe Dengue, because while untreated Severe Dengue has a fatality rate of 20-40%, timely identification and appropriate supportive care can reduce the fatality rate to less than 1%. We propose to create a simple, inexpensive, Point-of-Care (POC) test with visual plus/minus readout that will not only diagnose DENV infections early, but also be prognostic for Severe Dengue by quickly identifying patients who have secondary heterotypic infections, which is the major accepted risk factor for Severe Dengue. A simple, inexpensive POC test that provides timely, actionable prognostic results even in resource-limited settings would enable dramatic reductions in Severe Dengue morbidity and mortality while reducing health care costs by allowing clinicians to triage patients and focus resources effectively and efficiently.